AIRWAY EFFECTS OF REPEATED EXPOSURES TO OZONE IN HEALTHY AND ASTHMATICS

To evaluate the distal airway inflammatory response in smokers & non-smokers who are susceptible or nonsusceptible to ozone exposure.